Pathological Inflammation Alters Oligodendrocyte Differentiation and Function

PROJECT SUMMARY
Multiple sclerosis (MS) is the most common demyelinating disease of the central nervous system and
stems from autoimmune damage against the myelin sheath, which is necessary for rapid and efficient
conduction of electrical impulses along neurons. Oligodendrocyte progenitor cells (OPCs) serve a vital
role in regulating the progression of MS because they differentiate into myelinating oligodendrocytes to
restore myelin integrity in demyelinated lesions. However, many demyelinated lesions in MS experience
remyelination failure, a poorly understood phenomenon that may be triggered by neuroinflammation.
Recent evidence has showed that OPCs have notably decreased differentiation to oligodendrocytes and
interestingly adopt novel antigen presentation functions in settings that mimic neuroinflammation. Even
so, how the potential connection between these two separate phenotypes is biologically meaningful to
remyelination failure and what molecular mechanisms drive their occurrence in this disease state remain
unclear. To answer these questions, I developed a robust, scalable in vitro culture system to generate
pure OPCs from mouse induced pluripotent stem cells that are then treated with interferon-gamma
(IFNγ), a proinflammatory cytokine that is greatly increased in MS lesions and can broadly simulate the
neuroinflammatory milieu in this disease. Through bulk RNA-seq and high-throughput chemical screen
studies, I have found that STAT1 activity controls both IFNγ-induced phenotypes. In this proposal, Aim
1 will assess how IFNγ alters the temporal dynamics of differentiation and immune function activation to
gain greater insights into MS pathophysiology. Because I can precisely control IFNγ exposure, I seek to
probe potential transcriptional and functional memory in IFNγ-treated OPCs that can be broadly relevant
to relapsing-remitting MS, the most common MS subtype. I will also use special nanofiber plates for 3D
culturing of oligodendrocytes and interrogation of memory in myelination behavior (i.e. fiber wrapping)
by modulating IFNγ exposure over a longer duration. Next, Aim 2 will assess functional targets of STAT1
to determine mechanisms for these two phenotypes. In Ctrl- versus IFNγ-treated OPCs, I will perform
CUT&RUN for H3K27ac to assess genome-wide epigenetic changes and for STAT1 to determine its
global binding profile and how STAT1 can cause these changes in acetylation and also have context-
dependent functions. A rigorous computational pipeline will identify key differentially regulated genes
and pathways, and I will validate them in vitro via genetic knockdown studies and in human MS single-
cell RNA-seq datasets and patient brain sections. The experiments outlined here will significantly bolster
our knowledge of oligodendrocyte functional plasticity in remyelination failure and pave the way for new,
exciting therapeutic approaches that go beyond conventional MS disease-modifying therapies aimed at
immune cell depletion and instead harness the innate regenerative capacity of oligodendrocytes.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis (MS) represents the most common disabling neurological disease in young adults, but the underlying molecular mechanisms of MS remain elusive. This proposal will leverage stem cell and genomic technologies to gain valuable insights into how changes in the function of myelinating oligodendrocytes based on neuroinflammatory environmental cues are important in disease progression. The results of this proposal will contribute to the development of new, exciting therapeutic approaches for MS based on leveraging the innate regenerative capacity of oligodendrocytes.